Administrative Core A

Core A Abstract The Administrative Core will provide administrative and scientific oversight to all members of the Program Project Grant (PPG). The primary objective of the Administrative Core is to provide overall administrative support to the program, including efficient use of resources, providing feedback and oversight of cores to ensure quality and prioritize access, facilitating communication among projects and cores, and coordinating the meetings of the advisory committees. These activities will be under the direction of Dr. Steve Mifflin and he will be assisted by an administrative secretary (Ms. Marquez) and business administrator (Ms. Henson) with extensive experience in coordinating and managing the activities of multidisciplinary groups.